A druggable dependency in low-MITF/high-AXL melanoma: preclinical efficacy and mechanism of action in a key treatment-resistant subclass.

PROJECT SUMMARY
Despite major advances in targeted and immune therapies for melanoma, most patients experience relapses
or do not respond adequately. Acquired and intrinsic resistance to these therapies in both patient biopsies and
cell lines have been associated with a unique undifferentiated cell state characterized by low levels of MITF,
the master regulator of melanocyte development, and high levels of the AXL tyrosine kinase. This cell state is
reported in a high fraction of melanomas exhibiting de novo resistance to BRAF inhibition and in 50-100% with
acquired resistance. It is also a prominent feature of anti-PD1 resistant melanomas. Single-cell RNA-seq
demonstrated that all melanomas, even high-MITF ones, contain low-MITF subpopulations that are positively
selected by targeted therapy. To eradicate this population, AXL itself is not a therapeutic target, based on
published tests of multiple inhibitors and shRNAs. We therefore interrogated genetic dependencies using
Project Achilles—an unbiased genome-scale loss-of-function screen—and found that low-MITF/high-AXL
melanomas exhibit a striking dependency, not on AXL, but on LSD1, a lysine-specific histone demethylase that
has been implicated in oncogenic processes. We validated LSD1 dependence in multiple melanoma lines
using both genetic and pharmacologic inhibition. Analysis of melanomas in the TCGA and CCLE databases for
candidate LSD1 target genes mediating its dependency revealed three candidates that LSD1 selectively
modulates in low-MITF melanomas. The first of these, NDRG1, was shown to be required for LSD1-targeted
lethality. Concordance of these LSD1-target expression patterns is seen across both cell lines and tumors
(TCGA). We also show that SP2509, an LSD1 inhibitor related to a compound in clinical development, is highly
lethal to multiple low-MITF melanomas, an effect that is dependent upon (and modulated by) the low-MITF
state. Deeper analysis of the Achilles database identified multiple subunits of CoREST (known LSD1 co-
repressive complex) as strong dependency factors, phenocopying selective lethality of low-MITF/high-AXL
melanomas and suggesting a mechanistic connection to LSD1-dependency. In Aim 1, we will test the
hypothesis that therapeutic resistance of low-MITF melanomas can be mitigated by combining targeted or
immune therapies with LSD inhibition in early passage melanoma cell lines and PDX. Our preliminary results
demonstrate profound cooperative lethality by combining genetic or pharmacologic LSD1 inhibition with BRAF
inhibitor in vitro and in xenografts. We will test the ability of LSD1 inhibition to antagonize the emergence of
resistance in high-MITF melanoma, as well as to cooperate with agents that actively suppress MITF
expression. In Aim 2, we will mechanistically examine functional roles of four candidate mediators of LSD1
dependency and use genomic approaches to systematically scrutinize the low-MITF state, identifying potential
pharmacodynamic markers and mediators of LSD1 dependency. These findings provide a unique opportunity
to reveal mechanistic insights and therapeutic opportunities for important treatment-resistant patient subsets.

Public health relevance
Project Narrative Despite recent breakthroughs in systemic therapies for advanced melanoma, development of resistance to the most promising therapies remains a major obstacle. We have determined that a very important class of therapy-resistant melanomas depends on a particular enzyme for survival. We found that this enzyme, by modifying accessibility of DNA in the nucleus, regulates the expression of several genes that potentially control tumorigenic survival behavior. We will study these and other mechanisms of this key enzyme and test whether a candidate drug that inhibits the enzyme can overcome resistance to therapy exhibited by multiple melanoma models in mice.